INTRACRANIAL ANEURYSMS IN POLYCYSTIC DISEASE

Using multiple imaging modalities including four vessel angiography and dynamic computerized tomography and prospectively imaging asymptomatic autosomal dominant polycystic kidney disease- ADPKD- we will determine the incidence rate of asymptomatic intracranial aneurysms in ADPKD.